Dissecting the Role of Desmoplakin in Inflammation in Cardiomyopathy

Project Summary/Abstract
Desmoplakin is an elongated protein that links the desmosomal components to the cytoskeleton through
intermediate filaments. Heterozygous truncation mutations in the DSP gene, which encodes desmoplakin,
cause arrhythmogenic cardiomyopathy (AC) impacting the left ventricle. A striking feature associated with
DSP truncation variants (DSPtv) is a prominent inflammatory component, and this inflammation can be well
visualized through cardiac imaging using magnetic resonance or positron emission tomography. The effect of
DSP truncations in mediating cardiac inflammation is not well understood. The nature of DSP truncations
implies that haploinsufficiency or reduction of desmoplakin protein is contributory feature of left ventricular
cardiomyopathy with inflammation. To begin to characterize the transcriptional program associated with DSP-
cardiomyopathy, I analyzed RNA-sequencing from neonatal rat ventricular cardiomyocytes with siRNA to
reduce expression of DSP. Analysis of the differentially expressed genes in siRNA-treated cardiomyocytes
identified immune chemotactic pathways as having increased expression. Of particular note were several
genes connected to pyroptosis, an immunologically active form of cell death. Taken together, these data
suggest that innate immune pathways may contribute significantly to DSP-associated cardiomyopathy. I
hypothesize that reduction of desmoplakin promotes excessive inflammasome activation in cardiomyocytes
that results in aberrant calcium handling and pro-arrhythmogenic heterocellular junctions. In Aim 1 of this
proposal, I will assess this inflammatory component of DSP-cardiomyopathy in human-induced pluripotent
stem cell (hiPSC) lines with distinct DSP truncations derived from individuals with inflammatory-arrhythmogenic
cardiomyopathy. To characterize 2D- and 3D-hiPSC models, I will assess whether DSP haploinsufficiency is
sufficient to drive expression of inflammasome components. I will then examine DSPtvs for their effects on
contractility and calcium transients in response to pathogen- and damage-derived activators of the
inflammasome. I will conduct coculture assays of hiPSC-derived cardiomyocytes and fibroblasts to evaluate
the inflammatory modulation of heterocellular junctions and cardiac conduction in DSP-cardiomyopathy. In
Aim 2 of the proposal, I will modulate innate immune activation in hiPSC-derived cardiomyocyte models using
siRNA, small molecule inhibition, and epigenetic modulation strategies. These studies will target Never in
Mitosis A-related Kinase 7 (NEK7), an inflammasome component with differential gene expression in heart
failure. The proposed studies will expand from observations in patients with DSPtvs and define the
inflammatory triggers refining the distinct pathology related to DSP-mediated disease. In particular, the
findings from this study have implications for other forms of cardiomyopathy driven by fibrotic transformation
such as dilated cardiomyopathy and heart failure.

Public health relevance
Project Narrative Desmosomes are specialized complexes, necessary for normal cell interactions in the heart. Desmoplakin links the desmosomal components to the cytoskeleton through intermediate filaments, and genetic mutations that disrupt desmoplakin lead to an inflammatory form of cardiomyopathy with irregular heart rhythms. This study will assess the role of innate immune activation using human induced pluripotent stem cells (hiPSCs) containing truncating variants in DSP to demonstrate the potential for immune modulation in preventing disease progression of DSP-associated arrhythmogenic cardiomyopathy.